Plasma-induced signatures as a measure disease heterogeneity and immunomodulation in T1D clinical trials

PROJECT SUMMARY/ABSTRACT
A better understanding of Type 1 diabetes (T1D) pathogenesis has enabled development of
immunomodulatory strategies aimed at inducing clinical remission. While much has been learned, the positive
effects observed in these trials have generally been of limited duration and patient responses have been
mixed. It has been suggested that this outcome has stemmed from an incomplete understanding of the
complexity and heterogeneity of T1D pathogenesis. New measures of immune activity are needed to define
patient heterogeneity and identify mechanisms that could enable selection of targeted, personalized
therapies; monitor changes in the immune state associated with responses to treatment, and serve as
surrogate outcomes to shorten the duration of clinical trials.
To fill this gap we have employed an array-based bioassay, where subject serum/plasma is used to induce
transcriptional responses in a well-controlled peripheral blood mononuclear cell population. We find that pre
and new onset T1D plasma induces a disease-specific, partially interleukin (IL)-1 dependent signature
relative to related and unrelated healthy controls. We have used this approach to study participants of the IL-
1 antagonism trials and the TrialNet CTLA4-Ig trial. Our analyses revealed that varying levels of the
anticipated immunomodulation was achieved with these immunotherapies. Notably, plasma induced
transcription defined T1D subgroups, where those with the highest inflammatory bias prior to treatment,
experienced the greatest post-onset decline in stimulated C-peptide area under the curve and the greatest
therapeutic response.
Overall, our data support the hypothesis that heterogeneity in inflammatory and regulatory activity at
clinical onset can be used to stratify T1D patients into subgroups that differ in disease progression
rate and responsiveness to immune intervention. We propose the following Specific Aims:
Aim 1: To test the hypothesis that plasma induced signatures measured at baseline define ROT1D
subgroups that predict the rate of post-onset C-peptide decline and therapeutic responsiveness.
Aim 2: To test the hypothesis that T1D subgroups defined by plasma induced transcription exhibit
distinct immunological phenotypes.

Public health relevance
PROJECT NARRATIVE This project will benefit future Type 1 Diabetes trials by improving our understanding of disease heterogeneity and defining the common and unique effects past trials had on the inflammatory state. This will foster patient stratification, development of personalized therapies, and provide insight as to the combination of immunological pathways that must be targeted to recapitulate the immune state observed in healthy subjects.